Role of hepatic ploidy populations in liver injury and compensatory regeneration after acetaminophen overdose

PROJECT SUMMARY/ABSTRACT
Liver dysfunction is a major global health concern. In the U.S. alone, liver disease is the 10th leading cause of
death and afflicts nearly 30 million Americans. Managing and treating liver diseases is difficult and costly. In
cases of end-stage liver disease, liver transplantation is the most effective therapy, but it is severely limited by
donor organ supply, necessitating the development of therapeutic alternatives to whole organ replacement.
Extensive necrosis and poor regeneration observed in acute liver injuries can result in liver failure.
Acetaminophen (APAP), a common analgesic, can result in liver failure and death when taken in excess. A better
understanding of hepatocyte biology is required to improve existing approaches and innovate therapies for liver
disease treatment, including APAP-induced liver failure. Most somatic cells are diploid and contain single pairs
of homologous chromosomes, while hepatocytes are characterized by polyploidy, an increase in entire
chromosome sets. Polyploid hepatocytes comprise >90% of hepatocytes in adult mice and 25-50% in adult
humans. The cellular and molecular mechanisms that regulate polyploidization have been well characterized;
however, the functions of diploid and polyploid hepatocytes are poorly understood. In the context of liver
regeneration, diploid hepatocytes begin proliferating earlier and complete the cell cycle faster than polyploids,
suggesting that diploid hepatocytes drive an initial wave of proliferation. The overall goal of this project is to
understand how diploid and polyploid hepatocytes function during compensatory proliferation following APAP-
induced injury and the molecular mechanisms that contribute to these differences. The central hypothesis tested
in the proposal is that diploid and polyploid hepatocytes respond differently to APAP overdose, where
diploids resist APAP damage and drive critical, early-stage compensatory proliferation. This hypothesis
will be studied with 2 aims. Aim 1 will determine ploidy-specific effects on hepatocyte regeneration during APAP
overdose. Experiments will evaluate APAP-induced damage, compensatory regeneration, and mechanisms
regulating oxidative stress, specifically sirtuin signaling, in polyploid knockout models and cultured hepatocytes.
Aim 2 will investigate proliferation by human diploid and polyploid hepatocytes. Experiments will test the
regenerative and injury responses of diploid and polyploid cells isolated from human livers. Overall, this project
will expand our understanding of hepatocyte ploidy populations and their roles in acute liver injuries. These
findings may lead to the development of strategies or therapeutics to improve liver disease treatments.

Public health relevance
PROJECT NARRATIVE Liver disorders affect 30 million people in the United States and a better understanding of hepatocyte biology is urgently needed to improve existing approaches and to innovate therapies for liver disease treatment. Polyploidy (increases in whole chromosome sets) is characteristic of the liver, yet the functions of diploid and polyploid hepatocytes are poorly understood. The comprehensive research plan will expand our understanding of hepatocyte ploidy populations and elucidate the specialized roles played by diploid and polyploid hepatocytes in acute liver injuries.